Bioinformatics Shared Resource

BIOINFORMATICS SHARED RESOURCE (BISR): PROJECT SUMMARY
The rapid generation of highly complex biological and clinical data, along with the evolution of proteomics,
metabolomics, imaging, deep-learning, and single-cell analysis provides unprecedented opportunities for cancer
research. Concomitantly, it also presents major challenges for analyzing, integrating, interpreting, and sharing
these data. In 2017, based on feedback from internal and external advisors and the expanding bioinformatics
needs of the Wake Forest Baptist Comprehensive Cancer Center (WFBCCC) members, the former Biostatistics
and Bioinformatics Shared Resource was divided into two independent, but highly collaborative, shared
resources: the Biostatistics Shared Resource (BSSR) and the Bioinformatics Shared Resource (BISR). The
BISR was established by Co-Director Wei Zhang, PhD, who later recruited Umit Topaloglu, PhD, to serve as
Co-Director. The primary goal of BISR is to provide bioinformatics, data, and computational support for state-of-
the-art multi-omics, clinical, and population research efforts at WFBCCC. BISR is responsible for bioinformatics
and high-performance computing support, including study design, data analysis, visualization, and storage, and
preparation of peer-reviewed publications and grant applications. In response to WFBCCC members’ rapidly
growing demand, BISR expanded the genomic data analyses from traditional platforms (e.g., microarray,
sequencing) to the newest state-of-the-art genomics technologies, including 10X single-cell RNAseq, Visium
Spatial gene expression, ATAC-seq, and SPLiT-seq. Working closely with other WFBCCC Shared Resources,
especially the Cancer Genomics and the Proteomics and Metabolomics Shared Resources, BISR integrates
WFBCCC investigators’ analytic needs for genomics/proteomics/metabolomics for multi-omics projects. BISR
provides data support, management, and sharing for public omics databases such as TCGA, AACR GENIE,
CCLE, as well as data from WFBCCC’s Precision Oncology Initiative. It also uses the institutionally maintained
Translational Data Warehouse and the WFBCCC Cancer Registry. A cost-effective computational solution has
been established with Google Cloud computing, which has clocked more than 3.2 million computing hours. The
services provided by BISR increased by more than 200% since 2017, providing more than 22,900 service-hours
since 2017 to 186 researchers, of whom 137 (>73%) are WFBCCC members. Among the 59 WFBCCC
publications BISR contributed to, 13 have been published to date in high-impact journals (e.g., Lancet Oncol,
JAMA Oncol, Nat Commun, J Exp Med, Cancer Commun, Nucleic Acids Res, and Mol Cancer). BISR provided
support for 16 WFBCCC funded grants since 2017 to date: 1 U54 grant, 3 R01 grants, 1 R21, 2 NCI
Administrative Supplements, 4 DoD grants, 1 SU2C grant, 1 ACS grant, and 3 Foundation grants (1 ACSR grant,
1 V Foundation grant, and 1 NFCR grant). Based on the trending utilization data, BISR anticipates that the
service requests to the BISR will continue to increase by at least 30% every year, and expected to be covered
50/50 by extramural funding and increased WFBCCC intramural support.